International Brotherhood of Teamsters Hazardous Waste Worker Training Program Application

Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-003
Program Summary/Abstract (HWWTP)
Project Title: International Brotherhood of Teamsters Hazardous Materials
Worker Health and Safety Training
Application Organization Name: International Brotherhood of Teamsters
Address: 25 Louisiana Avenue, NW Washington, DC 20001
Project Director Name: Lamont Byrd
Contact Phone Number: 202-624-6960
Email Address: [email]
Website: teamsterworkertrainingprogram.org
Grant Program Funds Requested: $10,183,473
The International Brotherhood of Teamsters (IBT) Consortium is applying for funding to
conduct comprehensive health and safety training under the HWWTP to build institutional
competency and create a sustainable worker health and safety training program. Hazardous
waste remediation workers; construction workers at hazardous waste sites; and transportation
and warehouse workers encounter myriad occupational hazards such as: working at heights, in
excavations, heavy lifting, falling objects, electrical hazards, and exposures to chemicals.
Consequently, it is critically important for these workers to receive training to ensure that they
are able to identify occupational hazards and able to take actions to protect themselves, their
coworkers and the surrounding environment.
The IBT Consortium proposes to recruit workers within the targeted industry sectors through
relationships and partnerships with employers, unions, community-based organizations, and 10
regional training centers to conduct 995 classes for 15,745 workers during the 5-year funding
period. The IBT Consortium is in a unique position to deliver relevant, high quality health and
safety training to workers due to our infrastructure, mobile training capability, staffing,
extensive experience, and expertise.
The long term objectives and specific aims of the IBT Consortium are to increase worker,
community, and environmental safety and resilience by training workers to appropriately
respond to accidental releases of hazardous materials, work safely on hazardous waste
remediation projects, safely transport hazardous materials via truck, rail, or air, and safely
respond to natural disasters.
IBT Consortium Page 1 Program Summary-Abstract (HWWTP)